Investigating the Impact of Nicotine and Alcohol Co-Use on the Abuse Potential of Cocaine In Monkey Models

Cocaine use disorder (CUD) continues to be a major public health problem worldwide, with no FDA-approved
treatments. An important consideration in evaluating neural and behavioral mechanisms of CUD and potential
treatment strategies is the observation that most individuals suffering from CUD also co-use other substances,
including tobacco products and alcohol. The goal of this new research project is to extend the study of cocaine
misuse to include the co-use of nicotine and/or alcohol in female and male cynomolgus monkeys. When
alcohol and cocaine are co-used, there is an active metabolite formed, cocaethylene, which we recently
showed had reinforcing effects that were similar in potency and reinforcing strength to cocaine, when studied
under a progressive-ratio schedule of reinforcement. Preliminary data using a cocaine vs. food choice
paradigm, found that co-use of nicotine not only potentiated the reinforcing effects of cocaine, but it enhanced
the reinforcing strength of cocaine. Studies proposed in this application will extend the evaluation of cocaine
misuse to determine how nicotine and cocaethylene influence the ability of behavioral and pharmacological
interventions to decrease the reinforcing effects of cocaine and pharmacological interventions on the
discriminative stimulus effects of cocaine. In Aim 1, we propose to examine several behavioral interventions on
drug self-administration. For these studies, monkeys will choose between cocaine (including saline) and food
and the following interventions will be examined: delay discounting involving both food and drug (cocaine ±
nicotine and cocaethylene ± nicotine) delays; changes in the magnitude of the food reinforcer; and negative
punishment, using response-contingent timeouts. The studies in Aim 2 will examine the effects of chronic drug
treatments in female and male monkeys self-administering cocaine ± nicotine and cocaethylene ± nicotine in
the context of an alternative, non-drug, reinforcer (food-drug choice). We will combine chronic pharmacological
treatments with behavioral interventions in an effort to further decrease cocaine choice. The goals of Aim 3 are
to examine how nicotine and cocaethylene influence the discriminative stimulus effects of cocaine.
Pharmacological treatments examined on self-administration, will also be examined in this model of subjective
drug effects. The scientific premise for these studies is that co-use of nicotine and alcohol with cocaine result
in different behavioral consequences compared with cocaine alone and are not simply additive drug effects.
Thus, co-use of alcohol and/or nicotine with cocaine will require different behavioral and pharmacological
treatment strategies than cocaine alone. Results from these studies will aid in the development of personalized
medicine strategies for cocaine use disorder that incorporates polysubstance use.

Public health relevance
Relevance: The majority of people with cocaine use disorder (CUD) co-use other substances, including alcohol and nicotine. The research proposed in this application will utilize female and male monkeys self- administering cocaine and cocaethylene (an active metabolite formed with alcohol and cocaine are used together), with and without co-use of nicotine, to further explore behavioral (alternative reinforcers, impulsive choice, punishment), pharmacological (acute and chronic drug treatments) interventions and discriminative stimulus effects associated CUD. Results from these studies should aid in the development of personalized medicine strategies for CUDs that incorporate the co-use of other substances.